STRUCTURE OF RETROVIRUS CORES

This laboratory has been trying to determine the structure of retrovirus cores by cryoEM. They have been finding them to be somewhat heterogeneous and not icosahedral. They sent a sample to the STEM for mass analysis. It was very heterogeneous, with filled and empty capsids of different sizes, plus some tubes and sheets. Possibly a different preparation would be better. A new sample was more pure, but still appeared to have heterogeneous cores.